Data Management and Statistical Core

ABSTRACT: DATA MANAGEMENT AND STATISTICAL CORE
The Data Management and Statistical Core (DMS Core) provides modern data management and
operational support services, data integrity oversight via quality control and quality assurance, research,
scholarship, and statistical support, experimental design and logistics, and contributes to scientific publications
involving ADRC data and collaborators. The DMS Core is a central component of the ADRC, partnering with
the other cores and projects of the ADRC as well as outside investigators with access to the larger Department
of Biostatistics at UAB and their additional specialty resources. The Core provides data stewardship via a
robust and effective online Data Management Ecosystem developed over the past three years in collaboration
with other ADRCs. Using a combination of REDCap, SQL relational databases, and R/Python developed tools
and applications, we have leveraged our multicenter experience to enhance the retrieval, analysis, and
distribution of longitudinal Alzheimer’s disease and related dementias (ADRD) data. This architecture facilitates
local data management and quality control at UAB and enables a seamless conduit of ADRC UDS data
integration with the National Alzheimer’s Coordinating Center (NACC) and its affiliates. The Core tracks both
participant data generated by the other Cores and internal operational data to foster process improvement. A
key focus of the DMS Core will be in support of the research, education, and mentorship of new or ongoing
investigators in Alzheimer’s disease in the design and analysis of new projects, particularly for developmental
project applicants and participants in the Research Education Component of the ADRC. The faculty of the
DMS Core bring tremendous experience in ADRD and are involved in ADRC projects through all
developmental stages, from conceptual vetting, literature review, study design, monitoring, rigor and
reproducibility of analyses, to publication of research results. The DMS Core will contribute statistical and
methodological insights, developments, and educational aspects to the community through seminars,
interactions and presentations by DMS Core members, small group discussions, and mentoring of junior
investigators and staff.